Uncovering the functions of circRNAs in aging

PROJECT SUMMARY
Aging can be described as the progressive loss of cellular homeostasis and an increase in dysfunction over
time. One system that seems especially susceptible to the ravages of time is the central nervous system.
Brain function requires multilevel control of gene expression. In particular, regulation of RNA metabolism is
a major hub for regulation and recent research has shown a strong link between perturbation of RNA
metabolism and a number of neurological and neurodegenerative diseases for which aging is the main risk
factor and driving force. However, we still don’t know the exact links between RNA metabolism and aging.
Circular RNAs (circRNAs) are highly abundant RNAs produced by circularization of specific exons. As
circRNA production competes with RNA splicing, their biogenesis is per se a cis regulator of gene expression.
Moreover, several circRNAs also have functions in trans in tissues like the muscle and the brain where some
of them are translated. Interestingly, circRNAs have been shown to accumulate in an age dependent manner,
suggesting that they might be relevant for age-related homeostasis and/or pathogenesis. We recently
developed new biochemical and genetic tools that allow us to determine that a subset of circRNAs regulate
lifespan. Briefly, we generated a resource to knockdown (KD) circRNAs and identified 24 circRNAs that
alter lifespan when knocked down (KD). Interestingly many of the protective-circRNAs (those that diminish
lifetime when KD) are translated and are hosted by genes bound by FOXO, a key regulator of aging and
translation, suggesting a strong connection between circRNA translation, aging and FOXO. In addition,
we found that KD of circKlg and circSideIII result in strong and consistent lifespan extensions, increased
health spans as well as “younger transcriptomes” demonstrating a direct impact of these circRNAs on aging.
This proposal aims to expand these exciting results and mechanistically dissect the interplay between
circRNAs and aging pathways. For doing so, we will: 1) Determine the mechanism behind the aging-
promoting circRNAs; 2) determine the extent and requirements for circRNA translation and relationship to
aging and 3) define the relationship between the FOXO regulon and circRNAs in aging.
In sum, this project will illuminate key regulatory mechanisms of circRNA translation and the relationship of
these RNAs with aging. In addition, this project is highly innovative in its analysis of the general functions of
circRNAs, builds on strong preliminary results and the unique and constantly evolving expertise of our groups.

Public health relevance
PROJECT NARRATIVE The goal of the proposed project is to investigate a potential role of a new type of molecule (circular RNAs, circRNAs) in aging. Given the potential importance of circRNAs for neurodegenerative diseases and the obvious link with aging, this project will unravel key regulatory mechanisms of aging and aging-related diseases.